Ambient TLR Ligand Exposures and the Genesis of Asthma

DESCRIPTION (provided by applicant): During infancy and early childhood a subset of children with permissive genotypes develop aeroallergen hypersensitivities and asthma, while others do not. Epidemiological and laboratory investigations suggest that early life exposures to toll like receptor (TLR) ligands may have a profound impact on the genesis of asthma. Therefore, we propose to determine how airway exposures to purified TLR ligands and TLR ligands within house dust extracts (HDEs) impact on innate and adaptive immunity and subsequent responses to airway allergen challenge, in adult and 2-week old mice SA-I: Characterize how early life airway exposures to peptidoglycan (PGN; TLR2), LPS (TLR4) and immunostimulatory sequence oIigodeoxynucleotide (ISS-ODN; TLR9) influence innate and adaptive immunity and airway allergen tolerance- TLR2, TLR4, and TLR9 ligands are known to be ubiquitous and to induce divergent immunological responses. Therefore, we will compare PGN, LPS, and ISS-ODN induced maturation of lung associated DCs and their subsequent functionality in the immunological synapse with naive CD4 cells. In vitro and in vivo models will be utilized in comparative analyses of adult and 2-week old mice. In additional experiments, mice will be i.n. immunized with OVA alone or with PGN, LPS, or ISS-ODN, and immune and airway allergen challenge responses will be analyzed. SA-2: Characterize how early life airway exposures to TLR ligands contained in house dust extracts (HDEs) influence innate and adaptive immunity and airway allergen tolerance- Studies with purified PGN, LPS, and ISS-ODN will help define their unique immunological activities in the lungs. However, in the real world, potential asthmatic infants and toddlers are likely to have simultaneous exposures to a variety of TLR ligands and potentially other immunostimulatory elements, as well. Therefore, to complement studies with purified TLR ligands, we will first measure the LPS and Gram positive and negative bacterial DNA content of t-HDEs from homes that are tolerance (homes with livestock, dogs and cats etc.) and homes permissive for Th2 biased airway allergen hypersensitivities (homes without animal exposures). Then in studies analogous to those proposed in SA-1, we will determine how HDEs from tolerogenic and asthma permissive homes influence airway DC maturation, CD4 cell differentiation, and host susceptibility towards aeroallergen hypersensitivities in adult and 2 week old mice.